PE In Modulation of Energy Flux Through Oxphos

Project Summary
In this diversity supplement application, we propose a series of experiments and career development activities
for Dr. Cesar Meza, an incoming postdoctoral fellow for the Funai laboratory at the University of Utah. The
research will expand on the scope of the parent grant, by studying mitochondrial lipidome and bioenergetics in
the white adipose tissues. Not only does this topic synergize with Dr. Meza’s interests, acquiring techniques
essential to conduct these experiments will provide foundational skills for rigorous molecular biology research.
Proposed career development activities will also aid Dr. Meza to apply for individual postdoctoral fellowships
and for a career as an independent scientist.

Public health relevance
Project Narrative Flux through oxidative phosphorylation is regulated by mechanisms that are not completely understood. The proposed research will address fundamental questions on how the lipid composition of mitochondrial membrane regulates bioenergetics. Findings from these studies have implications for health and disease across multiple organ systems.